Attenuation of Liquid Formulation for PfSPZ Vaccine by X-Ray

PROJECT SUMMARY:
PfSPZ Vaccine, supported in clinical development by the International PfSPZ Consortium, is on track to be the
first US FDA-licensed vaccine against malaria or any human parasitic disease. The vaccine has been safe,
well tolerated, and protective against homologous (same strain) and heterologous (different strains) of
Plasmodium falciparum (Pf) malaria in 19 clinical trials in 11 countries. To date, 80–100% vaccine efficacy (VE)
has been shown against controlled human malaria infection (CHMI), VE that has been demonstrated for at
least 8 months against heterologous and 14 months against CHMI, and at least 18 months sustained VE
against intense transmission of heterogeneous strains of Pf in Burkina Faso with a 3-dose regimen. Trials in
Mali, Equatorial Guinea, and Germany have established optimized regimens in preparation for Phase 3 clinical
trials starting in Q1 2021, which will support a Biologics License Application to the FDA in 2022. PfSPZ
Vaccine is composed of radiation-attenuated, aseptic, purified, cryopreserved Pf sporozoites (SPZ). The
PfSPZ are produced in mosquitoes, and attenuated by -irradiation from a 60Co source while in the mosquitoes’
salivary glands. Our goals are to convert to irradiation of extracted, purified, PfSPZ in a suspension termed
vaccine bulk product (VBP) and to convert the PfSPZ attenuation process from -irradiation to X-irradiation.
Real-time ionization chamber dosimetry will be introduced to monitor dose administration and to ensure
attenuation. These three major changes to the process of attenuation will increase efficiency of manufacturing
and decrease the vaccine cost by: 1) allowing for fewer irradiation events of higher numbers of PfSPZ in
smaller volumes, 2) bringing the irradiation process inside the clean room facility; 3) eliminating costly 60Co-
related expenses, training, and security concerns, and 4) provide a more scalable process for mass vaccine
production. It will also establish a method suitable for attenuating in vitro-generated PfSPZ that are planned to
replace mosquito-produced PfSPZ in the next 4 years. X-irradiation was the method used in the 1967 proof of
principle studies demonstrating that attenuated rodent malaria SPZ could protect mice against malaria.
Subsequent studies adopted -irradiation for attenuation because this method was, at the time more accurate
and replicable. However, X-ray technology has vastly improved, and the benefits of X-ray attenuation make
this approach much superior to -irradiation. As Sanaria further scales up GMP manufacturing, plans to build
manufacturing plants in Africa and Asia, and aims to integrate in vitro-produced PfSPZ into PfSPZ Vaccine,
irradiation will optimally occur with the PfSPZ in liquid suspension as VBP. Inherently, X-irradiation is far more
efficient, amenable to scale up and cost effective than 60Co-irradiation. Three Specific Aims outline the work to
be performed: 1) Define the parameters to irradiate Vaccine Bulk Product liquid suspensions; 2) Determine the
minimal dose of X-irradiation required to completely attenuate PfSPZ; 3) Develop the use of ionization
chamber dosimetry for real-time monitoring of irradiation dose.

Public health relevance
PROJECT NARRATIVE: PUBLIC HEALTH RELEVANCE Of more than 2 billion people who live where malaria is transmitted, more than 200 million contract malaria each year. More than 400,000, mostly children in sub-Saharan Africa, die of malaria annually. These numbers will increase because the Covid-19 pandemic has interrupted malaria control programs. Malaria is also an ever-present threat to travelers visiting malaria-endemic regions. A new powerful tool is needed to eliminate Plasmodium falciparum malaria from defined geographical areas and ideally this would be a highly effective, long-acting vaccine that prevents infection, disease, and parasite transmission: Sanaria® PfSPZ Vaccine is the only candidate vaccine that has these characteristics. The goals of this proposal are to increase the efficiency of PfSPZ Vaccine manufacture and facilitate process scale-up leading to more vaccine being able to reach the populations in need more rapidly and at lower cost, and to introduce a new approach to weakening of the parasites that will facilitate building manufacturing plants throughout the world.